BCCMA: Targeting Gut-Microbiome in Veterans Deployment Related Gastrointestinal and Liver Diseases; CMA1- The Role of GWI Gut Microbiome in Susceptibility to Diarrheal Diseases

This revised BLRD and CSRD Collaborative Merit Award (BCCMA) application is being submitted as part of a
group of 5-linked CMAs from nationwide VA investigators in gastrointestinal (GI) and liver diseases, who formed
a national steering committee after participating in a successful field-based meeting in San Diego in May 2019
(funded by VAORD). The roadmap developed at this meeting was published in the journal “Gastroenterology”
(PMC7249241). This cluster of CMAs is aimed at in depth understanding of the emerging role of gut microbiome
in the pathophysiology of Veterans deployment related GI and liver diseases including the Gulf War Illness (GWI),
Post Traumatic Stress Disorder (PTSD) and Inflammatory Bowel Diseases (IBD), and to develop potential
biotherapeutics to alleviate the disease symptoms. This specific proposal CMA1, is driven by the facts that
while diarrheal disorders are highly prevalent in Veterans with GWI and are a major cause of high morbidity,
the pathophysiology of GWI is not well-defined, and the treatment options are inadequate. Therefore, in
view of the emerging role of the gut microbiome in GWI, there is a critical need to better understand the
role of microbial dysbiosis and the mechanisms involved in higher incidence of diarrheal disorders and IBS
in these Veterans. Recent studies have further highlighted the crucial role of gut microbiome in
susceptibility to diarrheal pathogens. For example, gut microbiome has been shown to be the key determinant
in susceptibility to infection and diarrhea by C. rodentium (CR, murine counterpart of the human
enteropathogenic E. coli). Additionally, fecal microbial transplant (FMT) based treatment strategies for C. difficile
infection further support the critical role of gut microbiome in diarrheal diseases. However, direct causal
relationship of microbial dysbiosis observed in GWI Veterans and diarrheal illnesses remains uninvestigated. In
this regard, in preliminary studies we established a humanized GWI mouse model where FMT from GWI
Veterans in mice for 14 days almost recapitulated some features of the functional bowel disorders associated
with GWI, including a) significant dysregulation in intestinal barrier integrity; and b) mild inflammation as
assessed by neutrophil infiltration. Another novel and striking finding in the humanized GWI mice was a marked
decrease in colonic expression of the key chloride transporter (DRA, Down Regulated in Adenoma). Of note,
decreased DRA expression is a key event in infectious or IBD associated diarrhea and is also linked to
compromised barrier integrity. Also, in preliminary studies, we observed that DRA KO mice were much more
susceptible to CR infection. Based on these data, we hypothesize that “Dysbiosis in GWI Veterans is
associated with compromised barrier integrity and decreased DRA expression which contributes to
increased predisposition of veterans to pathogen infections and diarrhea. We propose to utilize state-of-
the-art animal models e.g., the humanized and conventional GWI mice (exposure to gulf war chemicals), and
approaches using apical-out enteroids/colonoids, inducible DRA overexpressing transgenic mice, and in vivo
optical imaging system (IVIS) for in depth mechanistic understanding of the role of dysbiosis in GWI. We also
propose to investigate the role of biotherapeutics e.g., FMT from healthy Veterans, probiotics, and a bacterial
metabolite butyrate in alleviating gut dysbiosis, susceptibility to CR infection and gut barrier integrity. Two
Specific Aims are proposed: 1). Determine the susceptibility of humanized (FMT) and conventional
(chemical induced) GWI mice to C. rodentium induced diarrhea and elucidate the underlying
mechanisms; 2). Develop effective strategies aimed at correcting dysbiosis and diarrheal
phenotype in C. rodentium infected GWI mouse models. A successful outcome of the proposed studies
is likely to increase our understanding of the role of GWI microbiome in susceptibility to diarrheal diseases,
higher incidence of IBS (as repeated bouts of infectious diarrhea increase the risk of IBS) and has potential
of developing novel biotherapeutics for alleviation of dysbiosis and associated GWI symptoms.

Public health relevance
Emerging evidence supports the critical role of gut microbiome in development of Veterans’ deployment related GI and liver diseases. To date, however, the role of Gulf War Illness (GWI) microbiome in diarrheal diseases in GWI has not been investigated. The proposed studies in this application, based on our exciting preliminary data from a humanized GWI mouse model established by us are aimed at investigating the mechanisms underlying the higher incidence of diarrheal diseases in GWI veterans. We propose to utilize both the humanized mice (fecal microbial transplant or FMT from GWI veterans), and conventional GWI mice (war chemical induced) to understand the causative role of GWI microbiome in increasing susceptibility to diarrheal pathogens and the mechanisms involved. We will also assess the therapeutic role of FMT from healthy donors, probiotics and bacterial metabolite butyrate in GWI. The studies may unravel new targets for better treatment of GWI Veterans utilizing novel approaches to alter microbiome.